Real-time drug resistance emergence and spread in Africa

ABSTRACT
Genetic linkage using recombinant progeny from controlled experimental crosses is a powerful tool for locating
the genetic determinants that control important phenotypes. We have perfected the methods for quantitative trait
loci (QTL) mapping of malaria parasite traits using the humanized mouse model and have optimized bulk
segregant analysis (BSA) for streamlined identification of loci and prioritization of genes in the locus for functional
validation. The recent emergence of artemisinin resistant (ART-R) parasites in East Africa hastens the need to
understand the genes and mechanisms of fit, drug resistant parasites. The looming crisis of spreading resistance
to ART combination therapies (ACT) across Africa hinges on unique features associated with different kelch13
mutations appearing in different locales with different propensities to expand in frequency. Current surveillance
is to monitor kelch13 mutants and to assess cumbersome clinical phenotypes such as patient clearance half-life
and the labor-intensive Ring Stage Survival assay (RSA). We will partner with African researchers to target this
emerging crisis by generating experimental crosses between parasite strains that differ for important ART-R and
ACT-related traits to map the location of the genes and their mutations that control these phenotypes. We will
use both BSA selections (Aim 1) and clone-based QTL mapping (Aim 2). By judicious choice of parental lines
for constructing targeted experimental crosses Aim 1 will combine BSA with refined selection schemes; we
hypothesize that we can rapidly characterize kelch13 mutations and their phenotypic impacts, as well as their
broader whole genome profile to inform and improve surveillance. In Aim 2, we will deploy a range of novel
phenotypes we developed in the initial funding period, including a high-throughput adaptation of the traditional
RSA, along with an expansion of dosing regimens and recovery times. Aim 3 will apply these approaches to
individual progeny growth rates and comprehensive pair-wise competitive fitness. Working in concert with Core
B, we will identify additional genes and mechanisms that contribute to fit forms of ART-R. This approach will
allow us to test hypotheses about resistance evolution and characterize partner genes and pathways affected
by drug selections and identify the factors that influence the origins and spread of resistance.

Public health relevance
PROJECT NARRATIVE Genetic linkage studies can be powerfully applied to discovering genes that control important phenotypes of malaria parasites such as drug resistance. We will apply our new technology to routinely generate genetic crosses of malaria parasites using ‘humanized’ mice that express human liver cells to generate 10 new genetic crosses strategically designed to map genes involved in resistance to the drug, artemisinin. This form of drug resistance is emerging in Africa and beginning to spread, with likely devastating consequences if unchecked.